Association of Stigmatizing EHR Language with Clinician-Patient Communication and Patient Experience

ABSTRACT
Our healthcare system does not treat patients equally: some receive poorer quality care based on their racial/
ethnic identity, social class, health literacy, age, gender or medical conditions such as obesity, sickle cell disease,
and substance use disorders. While there may be many factors that contribute to these disparities, implicit bias
among clinicians is one important factor that remains difficult to measure. Clinicians may convey and acquire
bias towards patients from each other when communicating orally or when writing/reading medical records.
Although medical records are an integral method of communicating about patients, few studies have evaluated
patient records as a means of transmitting bias from one clinician to another. Our own preliminary work has
found that language used in medical records has a direct influence on subsequent clinicians who read the notes,
both in terms of their attitudes towards the patient and their medication prescribing behavior; that there are racial
disparities in the use of stigmatizing language; and that this language reflects actual attitudes held by the
clinicians. This is an important and overlooked pathway by which bias can be passed from one clinician to
another, further impairing healthcare quality for the individual patient as well as exacerbating disparities overall
for those who are stigmatized. Our overarching goal is to improve the quality and equity of care for persons who
are disrespected and stigmatized in healthcare. The specific aims of this proposal are: (1) to define and develop
a taxonomy of stigmatizing language in medical records using qualitative analyses with input from clinicians and
patients across 5 different medical specialty areas, (2) to measure and test for bias in the use of stigmatizing
language in medical records using natural language processing (NLP) that can efficiently detect and quantify
stigmatizing language in electronic patient records, and then (3) to reduce stigmatizing language in medical
records using proven implementation science (IS) strategies (stakeholder engagement, education, audit and
feedback, and champions) to motivate and enable health system change. Every encounter with a patient is
documented in the medical record. Because language may have a powerful role in influencing subsequent
clinician attitudes and behavior, attention to the language used in medical records could have a large impact on
the promotion of respect and reduction of disparities for stigmatized groups.

Public health relevance
Project Narrative This administrative supplement to the parent grant will support the career of Amanda McArthur, PhD, who comes from a background underrepresented in science. Further, the project Dr. McArthur undertakes will provide data about how stigmatizing documentation relates to observed interpersonal processes and patient experience of care. The project proposed here could provide compelling evidence of the need for change in the ways we document about patients.